Electrical Field Guided TMS and Constraint Induced Language Therapy to TreatPost-Stroke Aphasia in the Subacute Stage

Project Summary
Transcranial Magnetic Stimulation (TMS), sometimes in conjunction with Speech-Language Therapy, has been
demonstrated to improve language function in subjects with chronic aphasia in a number of small studies.
Several lines of evidence suggest that it is more effective when provided in the subacute stage after stroke but
its efficacy in this setting has not been adequately assessed. We propose to study the effects of continuous
Theta Burst Stimulation (a type of TMS) combined with a modified form of Constraint Induced Language
Therapy (mCILT) in 63 subjects with subacute aphasia. Subjects will be randomized in a 2:1 ratio to cTBS with
mCILT or sham cTBS with mCILT. After pre-treatment evaluation, subjects will receive 10 days of treatment;
post-treatment evaluations will be performed 3-5 days and again at 4 months after the completion of treatment.
We will use electrical field modelling to personalize stimulation intensity for each subject. Change from
baseline in the Western Aphasia Battery-Revised Aphasia Quotient at 4 months after the end of treatment will
serve as the primary outcome measure. A secondary aim is to identify anatomic and behavioral predictors of
response to treatment. Finally, a third aim is to identify the mechanism underlying the beneficial effect of the
treatment on brain organization using network neuroscience approaches. We will identify changes in the
strengths of connections between nodes in the language network to address specific hypotheses regarding the
effects of cTBS and mCILT on brain organization that are associated with beneficial response to treatment.

Public health relevance
Project Narrative Transcranial Magnetic Stimulation (TMS), sometimes in conjunction with Speech-Language Therapy, has been demonstrated to improve language function in subjects with chronic aphasia. We will use electrical field modeling to optimize TMS stimulation intensity in a double-blind study of continuous Theta Burst Stimulation combined with modified Constraint Induced Language Therapy as compared to sham stimulation and modified Constraint Induced Language Therapy in subjects with subacute aphasia. Additional aims are to identify anatomic, behavioral and genetic predictors of response to treatment and to identify the mechanisms underlying the beneficial effect of using network neuroscience imaging techniques.